Tactile and ultrasound imaging fusion for functional assessment of the female pelvic floor

SUMMARY Pelvic organ prolapse (POP) is a highly prevalent condition affecting at least 50% of women in the US during their lifetimes. Urinary incontinence (UI), as found in the US survey, affects from 15% to 38% of women. The true etiology of POP and UI and variations seen among individuals are not entirely understood. These disorders are thought to share a common pathogenesis, weakening (elasticity changes) of the muscular and connective support tissues, and pelvic floor muscle dysfunctions. Further progress in women's healthcare is possible if a patient with a damaged pelvic floor could undergo medical imaging and biomechanical diagnostic tests; the results of which could be fed into a patient-specific assessment and optimal treatment for that patient. In this project, we propose to develop and clinically validate a new approach for biomechanical characterization of structure components (ligaments, muscles, and fasciae) in the female pelvic floor. It will be based on a new device for Tactile + Ultrasound Imaging to allow static, dynamic (under tissue deformation) and functional (muscle contraction) characterization of the female pelvic floor. Tactile and ultrasound imaging fusion has a special fundamental importance because of the complementary nature of these technologies: tactile images provide stress data and ultrasound images provide strain data for the same region during tissue deformation. This allows elasticity assessment as a stress to strain ratio - physical parameter of tissue with high sensitivity to the pathology development. In the Phase I research, we plan development of a device ?-prototype and validation of its imaging performance in a pilot clinical study with 20 subjects at two clinical sites.

Public health relevance
NARRATIVE This project targets the development a new device for real time fusion of tactile imaging and ultrasound imaging to provide static, dynamic (under tissue deformation) and functional (muscle contraction) imaging and characterization of female pelvic floor prolapse and urinary incontinence conditions, which are common among women and require accurate diagnostics due to complexity of these disorders.